SERVICE

The service aspects of the Resource have been mainly focused on serving the needs of the collaborative research projects supported, but not funded, by the Simulation Resource grant. These include 2 PO1's and 5 RO1's, 1 R37 and 3 foreign-funded projects with 10 cardiovascular projects, 1 pulmonary projects, and 2 projects related to other organs and to cancer.